NIH-DOD Collaboration for Chemical Threats Affecting Cellular Respiration

Chemical threats to cellular respiration include chemical warfare nerve agents, pesticides, and various toxic industrial chemical/materials. The primary objective of this IAA is to support the research and early development of medical countermeasures (MCMs) against chemical threats that target cellular respiration. Projects supported under this IAA were developed jointly between the NIH/NIAID/CCRP and the DoD/USAMRICD. This IAA specifically focuses on the chemical threats sodium fluoroacetate, thallium sulfate, and cyanide. This IAA is administered under the oversight of the NIAID/OBRS/CCRP.